Task 6: Technical Support for Tuberculosis Therapeutics

This contract provides for administrative, management and technical support for development of tuberculosis therapeutics under the NIAID Preclinical Services for the Development of Interventional Agents Program.